SEDATIVE-STIMULANT COMBINATIONS-- EFFECTS ON HUMAN LEARNING

The aim of this proposal is to investigate the behavior and subjective effects of diazepam, triazolam both alone and in combination with caffeine, and d- amphetamine.